Project 3-- Determining biological and viral factors associated with clinical progression of cervical dysplasia in HIV-infected women

Abstract
High-risk human papillomaviruses (HR HPVs) are the causative agent for cervical cancer, with more than
80% of cases clustered in low and middle income countries (LMIC), and a further concentration in African
countries like Kenya and Uganda. There are preventive vaccines against HPV, but less than 2% of the world’s
target population has received them. This leaves millions of women at risk for cervical cancer. We need to
understand how HR HPV affects its host cell, dysregulates its environment, and, in regions with high rates of co-
infection of HR HPV and HIV, synergizes with HIV to drive cancer development and progression in women.
The greatest clinical risk factor for cervical cancer development is a persistent HR HPV infection. When
HR HPV infects the cervix, it changes the typical, sequential activation of cellular growth and differentiation
pathways both to support the HR HPV infection and to foster cancer development. In the presence of HIV, the
pathways and functions of HR HPV infected host cells are further disrupted, leading a more rapid progression to
cancer. We hypothesize that HR HPV infections manifest in predictable cellular gene expression changes that
are detectable in cervical samples, biopsy tissues, and peripheral blood. With HIV co-infection, we hypothesize
an additional, overlapping subset of augmented or unique gene expression changes are also detectable. As a
collective, these changes can serve as functional biomarkers to prospectively identify precancerous lesions and,
in the context of her HIV status, to stratify a woman’s future cervical cancer risk. Identifying and validating these
biomarkers is the goal of Specific Aim 1.
In addition to cellular biomarkers that predict cancer risk, the type and variant of HR HPVs is an important
predictor of morbidity and mortality associated with a cervical cancer diagnosis. Currently, there is a lack of
foundational data on the genetic landscape of variants of HPV 16, the most common HR HPV type in invasive
cervical cancers in Kenya and Uganda. We hypothesize that specific HPV 16 variants add to this region’s cervical
cancer risk; generating detailed data on HPV 16 variants is the goal of Specific Aim 2.
Our specific aims are: (1) Determine differences in host gene expression that prospectively discriminate
among HIV+ and HIV- women the risk for cervical dysplasia and precancerous lesions. We will leverage the
synchronous collection of cervical swabs and tissue, blood, and a clinical exam by visual inspection to quantify
host gene expression changes linked to pathology. (2) Determine the HPV 16 variants found in HIV+ and HIV-
women. We will investigate HPV 16 variants and conduct whole genome sequencing to create a detailed picture
of HPV 16 genetic polymorphisms. Through investigations of HR HPV, its host cells, and HR HPV in the context
of HIV, we will determine the biologic and virologic signatures designating a HIV+ or HIV- woman at risk for
cervical cancer development and progression. Studies for both aims will be performed in Kenya and Uganda,
expanding scientific research techniques and future pipelines of investigators in Sub-Saharan Africa.

Public health relevance
Narrative Recognizing that high-risk HPVs cause cervical cancer, and HIV can accelerate its development and progression, we will compare clinical screening examinations to collected biologic samples in order to quantify expression of functional biomarkers and identify HPV through typing and sequencing. These biomarkers represent the dysregulation human papillomavirus and HIV cause in their hosts; as such, by determining the expression and association of these biomarkers with clinical disease, and the virologic fingerprint of high-risk HPV found in Kenya and Uganda, we will create a roadmap to discriminate between women with greater risk for HPV-associated precancerous lesions, both with and without HIV co-infection.